GCRC BIOSTATISTICAL SUPPORT

To provide consultation on clinical study design, data analysis and data interpretation to GCRC investigators. To teach fellows and residents statistical methods and use of CLINFO as a biostatistical tool.